Short Course on Methods for MultiOmics Data Analysis

PROJECT SUMMARY / ABSTRACT
Large-scale molecular datasets have great potential to yield new biological discoveries and accelerate
biomedical research. However, specialized skills and training are needed to effectively access, integrate, and
interpret them. This project will address a shortage of these skills, by providing training and exposing students
to examples of successful reuse of large-scale data. To equip researchers with the necessary technical, scientific,
and implementation-related skills, we propose the Short Course on Methods for MultiOmics Data Analysis at the
Jackson Laboratory (JAX). This week-long course will focus on developing conceptual knowledge and practical
analytical techniques centered around rigorous analysis of Common Fund datasets. Our course will also focus
on building the soft skills needed to work effectively in collaborative research teams. Experts from Common Fund
projects including SenNet, KOMP2, GTEx, and the Metabolomics Workbench will serve as instructors and
mentors in the course. Our goal is to build an educational program that cultivates rigorous, reproducible practices
in managing and analyzing large-scale molecular data from the Common Fund while fostering effective,
productive research teams and long-term collaborations. Achieving these goals will strengthen scientific rigor
and broaden the impact of Common Fund data sets.

Public health relevance
PROJECT NARRATIVE Our Short Course on Methods for MultiOmics Data Analysis will increase knowledge of genomic data science, elevate the scientific and translational value of Common Fund data, and grow the community of Common Fund data users with an emphasis on women and underrepresented minorities. We will accomplish this through an intensive immersion experience in an environment that brings together participants and faculty with diverse backgrounds who share an interest in applying genomic data science in their work.